Lysosome and integrated stress response in aging and alcohol-associated liver disease

PROJECT SUMMARY/ABSTRACT
Alcohol-associated liver disease (ALD) is a major cause of chronic liver disease worldwide, claiming more than
3 million deaths globally (Liangpunsakul, Haber et al. 2016). The pathogenesis of alcohol-induced liver injury is
characterized by hepatic steatosis, inflammation, and fibrosis, which can progress to cirrhosis and liver cancer
(Gao and Bataller 2011, Williams, Manley et al. 2014, Nagy, Ding et al. 2016). Despite major progress in
understanding mechanisms for ALD, no successful treatment is available. Cells can adapt and protect
themselves in response to stress by activating cellular protective mechanisms such as autophagy, a cellular
catabolic process that degrades cellular proteins and subcellular organelles. Additional protective mechanisms
that are activated due to stress, such as the unfolded protein (UPR) and integrated stress (ISR) responses aid
in eliminating stress affecting the endoplasmic reticulum (ER). Autophagy and ER stress are tightly integrated
as ER stress can activate autophagy to regulate ER homeostasis and relieve ER stress. Our lab has been
studying autophagy in ALD and our previous work shows that alcohol consumption impairs hepatic autophagy
resulting in ALD. We demonstrated that alcohol activates mechanistic target of rapamycin complex 1
(mTORC1) and impairs transcription factor EB (TFEB)-mediated lysosomal biogenesis and autophagy. Aging is
a well-known risk factor associated with ALD. Alcohol consumption has increased in age groups older than 60
leading to an increased susceptibility to developing ALD in these groups. There is a lack of research that
focuses on alcohol consumption in older adults as the mechanisms by which alcohol and aging cooperatively
contribute to the pathogenesis of ALD in this age group remain incompletely understood. It is known that
autophagy and lysosomal functions decline with aging as well. Increased stress and impairment to the ER are
associated with chronic alcohol consumption as well as aging. My preliminary data showed impaired hepatic
TFEB function in aged mice, which is associated with altered mitochondria metabolic changes, hepatic
inflammation, and activated ER stress response systems in alcohol-fed aged mouse livers. However, how
autophagy and ER stress as well as aging regulate liver metabolism and contribute to ALD in aging population
is unknown. The overall goal of this project is to identify and understand the mechanisms in which aging and
alcohol consumption cooperatively contribute to the overall decline in liver function and the subsequent
development of ALD.

Public health relevance
PROJECT NARRATIVE Alcohol-associated liver disease (ALD) is a leading cause of liver failure with mortality rates projected to continuously increase over the next few years. As the average lifespan increases, the prevalence of chronic liver diseases like ALD increases especially in the older adult and elderly population. The proposed studies will help to elucidate the underlying mechanisms in which aging and alcohol consumption collaboratively influence and exacerbate the development of ALD by assessing the roles of TFEB-mediated autophagy and the involvement of the integrated stress response (ISR) mediated by ATF3 activation.